Path C NCDA&CS National Produce Safety CAP

Project Summary/Abstract
The NCDA&CS Produce Safety Program chooses Program PATH C to follow, which
includes conducting produce safety inspection under our own authority along with
completing other program objectives.
The NCDA&CS Produce Safety Program does intend to conduct sprout inspections
under Subpart M of the Produce Safety Rule in conjunction with the FDA.
The NCDA&CS Produce Safety Program has statutory authority to conduct inspections
and take enforcement actions per the North Carolina Food, Drug and Cosmetic Act.
The Program has adopted by reference with subsequent changes 21 CFR Part 112 –
Standards for the Growing, Harvesting, Packing and Holding of produce For Human
Consumption. (See 02 NCAC 09B .0116(o)(51))
Weblink: http://reports.oah.state.nc.us/ncac/title%2002%20-
%20agriculture%20and%20consumer%20services/chapter%2009%20-
%20food%20and%20drug%20protection/subchapter%20b/02%20ncac%2009b%20.011
6.pdf

Public health relevance
The Project Narrative This project, proposed by the North Carolina Department of Agriculture & Consumer Services (NCDA&CS), entitled NCDA&CS National Produce Safety CAP PATH C, is intended to continue the established Produce Safety Program to encourage safe production of fresh fruits and vegetables, promote compliance with the requirements of the Produce Safety Rule and improve public health protection. The NCDA&CS will continue their efforts to assess the North Carolina produce landscape, provide outreach, education and technical assistance to produce farms across the state, encourage verification of farm information and aim to achieve full compliance with the Produce Safety Rule by way of educational farm visits, regulatory inspections and other produce event response activities.